Training for Scientists Conducting Research to Reduce HIV/AIDS Health Disparities

ABSTRACT
This application seeks continuation of funding for the program “Training for Scientists Conducting Research to
Reduce HIV/AIDS Health Disparities” at the University of California San Francisco (UCSF). This program
addresses the urgent need to reduce HIV-related health disparities in the U.S. communities most affected by
HIV. Our training program provides education and mentoring to early-career social and behavioral HIV
researchers (hereafter Visiting Professors or VPs) who have demonstrated cultural expertise, a commitment to
improving the health of communities affected by HIV, and are initiating innovative programs of research to
advance the objectives of the Office of AIDS Research Annual Strategic Plan and program priorities of the
NIMH Division of AIDS Research (DAR). The aims of this five-year project are to: (1) Support VPs in refining
innovative ideas, concepts, and theories into clearly articulated and rigorous HIV health disparities research
with HIV-impacted communities; (2) Fund an individualized applied research experience (ARE) to accelerate
VPs’ research programs and generate findings to be used as preliminary data in NIH grant proposals; (3)
Provide education and mentoring to VPs in the conceptualization, writing, submission, revision, and
resubmission of NIH research proposals through use of an individual development plan (IDP), mentoring
meetings, seminars, webinars, writing retreats, and peer networking; and (4) Provide ongoing individualized
assistance and mentoring focused on research and career development through peer reviews and
consultations to VPs who have completed the program. We will accomplish these aims through a research
education and mentoring program at UCSF’s Center for AIDS Prevention Studies (CAPS). The centerpiece of
the proposed program is a summer training institute in which VPs, who have not yet obtained R01-level
funding, participate intensively over a three-year period. Each VP is in residence at CAPS for six weeks for
three consecutive summers. In the first summer, the training institute helps VPs develop their ideas into
feasible programs of research so that they are poised to implement an applied research experience over the
next year. During the second summer, VPs begin an NIH grant proposal, incorporating results gleaned from
their program-funded applied research experience. Following the second summer, they finalize their grant
proposal and submit it to NIH. In the third summer, they revise and resubmit their proposals to NIH. The
activities are additionally enhanced through webinars and meetings with faculty mentors scheduled during the
academic year. Alumni receive additional support to remain in the HIV research pipeline through alumni peer
reviews, writing retreats, and participation as alumni experts in the summer institutes. The proposed program is
well positioned to leverage CAPS’s unique environment to provide tailored research education and mentoring
in social/behavioral HIV research, assist program participants to become successful independent investigators,
and simultaneously increase the diversity of HIV scientists.

Public health relevance
PROJECT NARRATIVE Building human resource and infrastructure capacity to enhance sustainability of HIV research discovery and the implementation of findings by a diverse and multidisciplinary workforce is a major goal of the National Institutes of Health’s strategic research plan for HIV and HIV-related research. The proposed five-year program aims to address this public health need by providing research education and mentoring to early- career social and behavioral HIV researchers who have demonstrated cultural expertise, a commitment to improving the health of communities disproportionately affected by HIV, and who are initiating innovative programs of research to advance the program priorities of the NIMH Division of AIDS Research. The core of the program is: an innovative, intensive six-week summer in-residence program of seminars and peer reviews; one-on-one consultations with mentors; research experience funding; ongoing support from mentors and webinars during the academic year; and one-on-one consultations and peer reviews for VP alumni to support them in submitting new NIH grant proposals and remaining in the research pipeline.